NURTURING GENOMICS AND BIOINFORMATICS RESEARCH CAPACITY IN AFRICA (BRecA)

Abstract
the “Nurturing Genomics and Bioinformatics Research Capacity in Africa” (BRECA) program
has for the last last five years supported the development of sustainable bioinformatics
research capacity at Makerere University, to achieve a critical number of well-trained
bioinformaticians in the long-term. This has built on the momentum of prior H3Africa
supported consortia i.e., CAfGEN, TrypanoGEN, IBH3AU & H3BioNET. However studies of
the bioinformatics students – Master’s and PhD, were disrupted when all forms of education
in Uganda, including that in tertiary institutions, was suspended and closed for 2 years (at
the beginning of 2020) due to the COVID-19 pandemic. Although Master’s trainees have
been able to complete their training on time, PhD trainees were unable to complete due to
the requirement of a more rigorous training (in terms of research outputs and contribution to
the filed). Therefore the purpose of this supplement application until August 2023 is to
enable three PhD fellows complete their studies.

Public health relevance
The proposed activities will enable the PhD fellows enrolled on the program at Makerere University to complete their studies. These will be the first bioinformatics Doctoral graduates at Makerere University, who will contribute towards the realization of sustainable bioinformatics research capacity in Uganda.